Healthcare Access Dimensions and Racial Disparities in Lung Cancer

PROJECT SUMMARY/ABSTRACT
Lung cancer is the leading cause of cancer death in the United States. Advances in lung cancer treatment
have substantially improved survival. However, the benefit has not reached all racial/ethnic groups of patients
equally. Compared with non-Hispanic European Americans (EA), non-Hispanic African Americans (AA) are
disproportionately affected by lung cancer with higher incidence and inferior survival. Their poorer outcomes
are largely driven by more advanced stages at diagnosis and underutilization of stage-appropriate treatment.
Importantly, AA and EA patients with lung cancer can achieve comparable outcomes under similar treatment
modalities. This strongly suggests that barriers to cancer care are central to outcome disparities, and strategies
targeting specific barriers will be critical to reduce long-standing disparities. However, studies addressing the
underlying mechanisms of lung cancer treatment disparities have focused on non-modifiable and much less
modifiable factors. There is an urgent need to elucidate modifiable factors influencing lung cancer treatment in
AA patients. As Penchansky proposed, healthcare access consists of five distinct dimensions, including
affordability, accommodation, acceptability, availability, and accessibility. However, most of previous studies
assessed access to lung cancer care based on insurance coverage and availability of providers, and other
dimensions of access remain critically understudied. We found that insurance coverage and availability of
cancer care collectively explained <50% of the excess risk of underutilization of guideline-concordant treatment
in AA vs EA lung cancer patients. Thus, we hypothesize that excess risks of underutilization of guideline-
concordant lung cancer care and mortality in AA vs EA patients are attributable to access barriers AA patients
disproportionately experience. To test this novel hypothesis, we will develop an integrated database with AA
and EA patients diagnosed with non-small cell lung cancer, primarily including data from the longitudinal
SEER-Medicare database, national annual surveys of population-based samples of Medicare enrollees, a
nationwide database of providers, and neighborhood contextual measures. Using advanced spatial statistical
modeling to account for clustering within providers and neighborhoods, we will simultaneously assess five
access dimensions in association with lung cancer care and outcomes (Aim 1), examine racial differences in
access dimensions overall and by indicators of social disadvantage (Aim 2), and further quantify the
independent and collective contributions of access dimensions to racial disparities in lung cancer care and
outcomes (Aim 3). This will be the first population-based study to comprehensively assess the impacts of all
five access dimensions on lung cancer treatment and their contributions to lung cancer disparities. The results
will provide novel insights into which specific components of access are most important and potentially
modifiable in explaining lung cancer disparities, as well as where in the lung cancer care continuum they may
be most amenable to intervention to improve lung cancer care for AAs and reduce disparities.

Public health relevance
PROJECT NARRATIVE Despite long-standing racial disparities in lung cancer treatment and outcomes, the underlying reasons remain inadequately understood. We will comprehensively and simultaneously assess the contributions of affordability, accommodation, acceptability, accessibility, and availability barriers to lung cancer disparities in a nationally representative cohort of lung cancer patients. The results will advance our understanding of the potentially modifiable barriers to lung cancer care in African American patients, and thus will help inform multilevel intervention strategies to improve lung cancer care and reduce the burden of lung cancer in this vulnerable population.